Sodium Dependent Inactivation of the Na+-Ca2+ exchange: Relevance to Cardiac Function

PROJECT SUMMARY/ABSTRACT
Na+ and Ca2+ ion homeostasis are essential for heart excitability and contractility. At the cellular level the plasma
membrane protein Na+-Ca2+ exchanger (NCX) plays a vital role in regulating the ionic homeostasis of both Na+
and Ca2+. It does so by extruding one Ca2+ out of the cell in exchange for three extracellular Na+ ions. In addition
to being transported, both these ions allosterically regulate the activity of NCX. Intracellular Ca2+ increases NCX
activity while cytoplasmic Na+ inactivates NCX via a process known as Na+-dependent inactivation. Despite the
potential physiological and pathophysiological relevance of this regulation, whether the Na+-dependent
inactivation occurs in vivo is unknown and its impact has yet to be determined. Since this is such an exquisite
controlling system, but heretofore uninvestigated, the investigators hypothesize that small changes in cellular
Na+ concentrations may have significant effects on Ca2+ homeostasis by directly affecting NCX activity and
thereby affect excitability and contractility of the heart. Therefore, the goal of this application is to investigate the
physiological impact of NCX Na+ modulation and determine how it ultimately shapes heart contractility. These
studies have been hampered by the difficulties of studying this process in intact myocytes under controlled
conditions. However, with the development of genomic modification via CRISPR technology, this experimental
paradigm, heretofore out of reach, can now be addressed. Using CRISPR, the investigators have inserted a
single site mutation (K229Q) in the native cardiac NCX gene of mice, which will exclusively abolish Na+-
dependent inactivation. By combining electrophysiology and calcium imaging techniques, the collected novel
preliminary data demonstrating that the inhibition of NCX by cytoplasmic Na+ alters the electrical and mechanical
properties of both single cells and intact hearts.
The work proposed here is organized into two aims. Aim 1 will investigate how the absence of Na+-dependent
inactivation alters excitation-contraction coupling in mouse adult ventricular myocytes by comparing, action
potentials, Ca2+ transients and ionic currents measured from adult ventricular myocytes isolated from either
control (WT) or the genetically altered mice (K229Q). Aim 2 will conduct similar recordings but in intact perfused
hearts. Additionally, the cardiac function of live K229Q mice will be assessed using echocardiography.
These investigations are groundbreaking as they will detail the potential function of NCX allosteric Na+ regulation
in cardiac function. This work may also have pathophysiological applications by defining the regulation of Na+ as
a potential target for controlling NCX activity.

Public health relevance
PROJECT NARRATIVE This proposal aims to investigate how the allosteric regulation of the Sodium-Calcium Exchanger (NCX) by intracellular sodium affects heart function. NCX influences heart contractility by extruding cytoplasmic Ca2+ and alterations in its activity are associated with pathological conditions such as chronic heart failure and ischemia- reperfusion. Understanding NCX mechanisms of regulation and their potential physiological impact will assist in designing ways to modulate NCX activity, helping advance knowledge of treatment for heart failure and in developing new therapeutic and pharmacological applications.